Wicked Smart Pad: Washable Sensorized Bedding for the Prevention and Detection of Moisture Events

Project Summary/Abstract:
Due to decreased mobility, deterioration in activities of daily living, and neurological decline that contributes to
loss of bladder control, incontinence is a leading comorbidity for those individuals suffering from Alzheimer’s
disease and related dementias (ADRD). Further, individuals with incontinence are susceptible to the
development of pressure ulcers (PUs), with nearly 40% of advanced dementia patients developing PUs.
Rightly, there is heighten concern that increasing rates of dementia will lead to higher rates of PUs, resulting in
increased suffering and mortality in the ADRD population. While the impact of PUs in the acute setting is well
understood, there is a range of potential iatrogenic skin injuries regarded as an inevitable part of aging that
remain underappreciated and under-investigated in ambulatory memory care units and assisted living (AL)
facilities. Maintaining skin integrity in ADRD patients is an ever-present challenge for healthcare providers and
caregivers, as well as a significant financial burden. Early detection of moisture events mitigates the
complications associated with incontinence, improving the quality-of-care patients receive. While efforts have
been made to address incontinence through product innovation, none have utilized a fully integrated systems
approach that incorporates unobtrusive sensor technology, early detection, and has a positive environmental
impact. Wicked Sheets, a Kentucky-based, woman-owned business, has developed the Wicked Smart Pad, a
washable and reusable, sensorized bedding pad system. It alerts caregivers when a moisture event occurs via
wireless communication, collecting vital information to support the care team. In Phase I, the PI and the
collaborating site, Atria Park of Great Neck, New York, will determine the feasibility and usability of the
sensorized bedding pad system, evaluate its acceptability by care staff and residents alike. Aims: 1: Evaluate
the feasibility, usability, and durability of the Wicked Smart Pad for individuals with ADRD in an assisted living
home. 2: Evaluate usage and acceptability of care staff interaction with the Wicked Smart pad. 3: Engineer
power-efficient firmware that collects and transmits moisture event data through a HIPAA compliant wireless
network, which integrates within the test site’s network on a user-friendly dashboard. At the end of Phase 1,
Wicked Sheets will have implemented the Wicked Smart Pad to patients with ADRD in an assisted living
community, received feedback on the bedding, hardware, and software from the end-users, and assessed the
ability to collect moisture samples. Phase II efforts will include device and firmware enhancements. This novel
technology serves as a prevention and intervention tool for care staff, ADRD family members, and the
healthcare community at large to reduce the burdens of the workforce and financial strain, enhancing the
quality of life and care of those individuals living with ADRD.

Public health relevance
Project Narrative: Patients suffering from Alzheimer’s disease and related dementias (ADRD) are at a significantly higher risk of developing pressure ulcers (PUs) and skin breakdown, particularly when incontinence is present. Incontinence and PU contribute to declining quality of life for ADRD patients and increased caregiver distress, causing strain on the healthcare system. Wicked Sheets has developed the Wicked Smart Pad: a washable and reusable, sensorized technology that provides ADRD caregivers with early detection of moisture events, mitigating the complications associated with incontinence, improving the quality-of-care patients receive.